MULTIPHOTON MICROSCOPY OF NHLF EMBEDDED IN COLLAGEN AND FIBRIN GELS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Using multiphoton microscopy to detect second harmonic signal from collagen (newly synthesized and matrix)as a tool to quantify fibrosis of airway remodelling in asthma.